Glycemic control and frailty risk in older people at risk for type 2 diabetes: Impact of local heat therapy

Project Summary/Abstract
Frailty-related medical expenses cost approximately $18 billion annually in the USA. Progressive losses in
skeletal muscle (SKM) mass and function, often observed with aging and type 2 diabetes (T2D), contribute to
phenotypic frailty characterized by slow gait speed, weakness, weight loss, fatigue, and low physical activity.
T2D increases frailty risk by nearly 50% and risk for both conditions increases with age; therefore, preventing
progression to T2D in older adults with prediabetes is critical. Additionally, SKM is the largest glucose disposal
site in the body and insulin responsiveness, a component of glycemic control, is essential to maintain functional
SKM mass. Thus, impaired glycemic control, a pathophysiological change underlying the development of T2D
and observed in prediabetes, increases frailty risk. Conversely, improving capillarization and mitochondrial
function support increased SKM mass and glycemic control, thereby decreasing T2D and frailty risk. Together,
these SKM architectural variables (e.g., cross-sectional area [CSA], capillarization, mitochondria) are attractive
targets for interventions such as exercise in prediabetic older people. High-intensity interval training (HIIT) has
been used effectively in older adults with SKM benefits similar to those from aerobic and resistance training, and
is more time-efficient. However, prediabetic older people may be exercise-intolerant or -resistant, underscoring
the need for alternative therapies in place of (or in addition to) exercise. Emerging evidence supports repeated
heat therapy as an alternative method to improve glycemic control and SKM architecture, and such adaptations
may also improve muscle growth responses to subsequent exercise. Heat-sensitive transient receptor potential
vanilloid receptor 1 (TRPV1), a highly Ca2+-permeable ion channel, is a promising mechanistic candidate
underlying SKM adaptations to repeated heat stress. While whole-body heat therapy is widely studied, local heat
therapy (e.g., heat pad) is more practical and likely provides similar health benefits. Whether local heat therapy
would have similar benefits to HIIT or whether heat pre-conditioning would improve adaptations to subsequent
HIIT in prediabetic older adults is unknown. Therefore, the overall hypothesis of this ESI R01 application is that
local heat therapy improves SKM architecture, glycemic control, and subsequent exercise adaptations, and
decreases frailty risk in prediabetic older adults, with TRPV1 as an underlying mechanism. The project’s specific
aims will test whether: 1) local heat therapy improves SKM architecture, glucose tolerance, and frailty indicators
similar to HIIT in older prediabetic people; 2) local heat therapy pre-conditioning improves the SKM response to
HIIT in older prediabetic people; and 3) TRPV1 mechanistically underlies SKM adaptations to heat therapy. The
findings of this study will provide evidence supporting a directly translatable local heat therapy intervention for
older adults at risk for T2D. In line with the Katz mechanism, the proposed work leverages the expertise of the
PIs and represents a shift in research focus. We propose to test a highly practical and promising intervention to
combat metabolic complications in aging, a crucial area of study with the current aging population.

Public health relevance
Project Narrative Aging people with prediabetes are at increased risk for frailty, and skeletal muscle architectural factors (which may improve with exercise or heat therapy) could underlie development of frailty and progression to type 2 diabetes. The proposed study will test local heat therapy as a method to improve skeletal muscle architecture (i.e., cross sectional area, capillarization, mitochondria), glucose tolerance, and frailty indicators in prediabetic older adults. Data generated will provide evidence supporting a directly translatable, easily implemented therapeutic intervention to ameliorate risk of developing overt type 2 diabetes and frailty in at-risk aging individuals.